Potential New Barriers to Home Health Access for People with Alzheimer's Disease and Related Dementias

PROJECT SUMMARY/ABSTRACT
Candidate: I am an assistant professor in the Division of Physical Therapy in the College of Health
Professions at the Medical University of South Carolina in Charleston, South Carolina. My long-term goal is to
become a well-funded, independent researcher investigating post-acute care of individuals with Alzheimer’s
Disease and Related Dementias (ADRD). To achieve this goal, I will build upon my clinical expertise and
current research training. For the K01 period, I have set four short term training goals/objectives: (1) Develop
competence in post-acute care policy impacting people with ADRD, (2) Develop skills in management and
manipulation of Medicare data of people with ADRD, (3) Develop competence in propensity score methods
and data analysis for data of people with ADRD, and (4) Enhance my grantsmanship, ethical conduct of
research, and mentorship skills for career development and advancement.
Mentoring Team: My Primary Mentor is Kit Simpson, DrPH and my Co-Mentor is Kenneth Ottenbacher, PhD,
OTR. Additional members of the mentoring team include Annie Simpson PhD, Jacobo Mintzer, MD, MBA, and
Kathryn H Bowles PhD, RN, FAAN, FACMI. My mentoring team is highly qualified and includes nationally and
internationally recognized experts in health services research (K. Simpson), post-acute care quality measures
(K. Ottenbacher), ADRD (J. Mintzer), study design and analysis methods for observational studies (A.
Simpson), and home health practice, policy, and research (K. Bowles). My mentoring team will guide career
development activities and participate in the K01 research.
Research Strategy: Medicare home health underwent unprecedented changes in 2020 due to the COVID-19
pandemic and a new payment model. These vast changes threaten to exacerbate existing barriers to home
health access for people with ADRD. Decreased access to home health causes harm to people with ADRD
and can trigger a cascade of resource and financial implications for the health care system. Impacts of the
current crisis on home health access and quality for people with ADRD has not been examined but is urgently
needed. This K01 project will use well matched groups, to show the impact of reimbursement change and
pandemic disruption on home health access and outcomes for people with and without ADRD through analysis
of Medicare assessment and billing data. Propensity score methods will be used to balance patient risk factors
for comparison groups. Aim 1: Describe differences in home health access and outcomes between well-
matched groups of Medicare Beneficiaries (MBs) with and without ADRD in 2019. Aim 2: Examine changes in
home health access and outcomes for well-matched groups of MBs in 2019 vs 2020. Aim 3: Examine changes
in home health access and outcomes for well-matched groups of MBs in 2019 vs 2021. Findings from this
study can help to optimize access, cost, and outcomes for people with ADRD and the Medicare system and
inform advocacy efforts, current home health practice, and future post-acute care policies.

Public health relevance
PROJECT NARRATIVE Home health is an ideal post-acute setting for people living with Alzheimer's Disease and Related Dementias (ADRD), yet, people with ADRD experience barriers to accessing needed health care services. Unprecedented changes in home health in 2020 due to pandemic disruption and implementation of a new reimbursement model pose a significant threat to home health access and quality for people with ADRD. This study examines the impact of these changes on home health access and quality of care for people with ADRD and will inform advocacy efforts, current home health practice, and future post-acute care health policy.